Molecular Tools to Study FLVCR2-mediated Heme Transport in Brain Angiogenesis

PROJECT ABSTRACT
The blood-brain barrier (BBB) is a term used to describe the unique properties of the blood vessels that
vascularize the central nervous system (CNS) and restrict the movement of molecules, ions and cells between
the blood and the brain. BBB dysfunction contributes to various CNS diseases and greatly impedes drug delivery.
Despite its importance, little progress has been made in manipulating the BBB due to a major gap in our
understanding, and a lack of tools to interrogate, constituents of the BBB at a molecular and cellular level. Our
recent work and preliminary data begin to characterize a role for FLVCR2, a plasma membrane heme
transporter, in brain vascular development and disease. Flvcr2 is specifically expressed in BBB endothelial cells
and its mutation in humans causes Proliferative Vasculopathy and Hydranencephaly Hydrocephalus PVHH - a
rare genetic condition characterized by defective brain angiogenesis leading to ischemia and ventriculomegaly.
Our work links BBB heme transport to brain angiogenesis, and uncovers a central role for heme in these
pathologies. However, the mechanisms by which FLVCR2 transports heme and controls brain angiogenesis are
unknown, and we currently lack the tools to probe these mechanisms at a molecular level. In this proposal we
will address this void through two specific Aims: In Aim 1, we will determine the structure of FLVCR2 using
cryo-electron microscopy (cryoEM), so as to provide a model to generate structure-based functional hypotheses.
In Aim 2, using CRISPR-Cas9 technology combined with innovative heme reporters and angiogenesis assays
well-known to our lab, we will develop cell-based angiogenesis assays to allow rapid and efficient testing of
structure-based hypotheses. Our preliminary data include cryoEM analysis of recombinant FLVCR2 and complex
formation with FLVCR2-specific antibodies (Fabs); and the manipulation of Flvcr2 expression in cell culture
angiogenesis assays utilizing mouse brain endothelial cells. These data demonstrate that we are well-poised for
structural determination and the development of an adaptable cell-based assay for future structure/function
studies on FLVCR2, and its role in BBB heme transport and CNS disease.

Public health relevance
PROJECT NARRATIVE FLVCR2 is a heme transporter specifically expressed at the blood brain barrier, where its mutation suppresses angiogenesis and causes is a genetic form of hydrocephalus. The objective of the experiments proposed here are to provide the community with tools to study FLVCR2 at a molecular level.